Animal Feed Regulatory Program Standards

Project Summary - Abstract
The mission of the Office of Indiana State Chemist (OISC) is to protect public
consumers, livestock, pets, and manufacturers from misrepresented or unsafe feed,
fertilizer, seed, and pesticide products, and from misuse that may result in harm to
animals, people, or the environment. This mission is fulfilled through science-based
regulation, truth in labeling, education and training of users, and active enforcement of
state and federal laws. OISC’s regulatory approach ensures safety in the marketplace,
responsible use of agricultural products, and support for the goals of the Integrated
Food Safety System (IFSS).
This proposal supports Indiana’s continued implementation and advancement of the
Animal Food Regulatory Program Standards (AFRPS). During Years 1 and 2 of this
funding cycle, OISC will finalize documentation and processes to close remaining
program gaps and continue improvements in procedures, training, inspectional
consistency, sampling, and enforcement practices. In Year 3 of this funding cycle, OISC
will transition to the AFRPS Maintenance Track, maintaining full implementation with an
emphasis on continuous improvement, internal audits, and consistent compliance and
enforcement.
Under this proposal, OISC is requesting $300,000 annually in grant funds for the first
two years (AFRPS Development Track), and $225,000 in the third year (AFRPS
Maintenance Track). Grant funds will support one full-time equivalent (FTE) employee,
training, travel and collaborative work with FDA and other state programs, and
equipment and supplies to strengthen Indiana’s feed safety infrastructure. This
cooperative agreement will develop and sustain a high-quality, standards-based
regulatory feed program that reduces the risk of animal feed contamination and
contributes meaningfully to national food safety efforts.

Public health relevance
Project Narrative for Animal Feed Regulatory Program Standards Implementation and Maintenance for the Office of Indiana State Chemist: Animal Food Regulatory Program Standards (AFRPS) Implementation and Maintenance under PAR-25-003 (U2F) will allow the Office of Indiana State Chemist (OISC) to further enhance a risk-based animal feed safety program; establish and sustain a uniform foundation for the design, management, measurement, and improvement of regulatory operations; and advance OISC’s mission to protect public health through effective oversight of animal feed. Through continued implementation of AFRPS, OISC will strengthen its ability to direct regulatory activities toward preventing foodborne illness linked to feed-related hazards in materials, ingredients, and manufacturing environments. This cooperative agreement will support efforts and infrastructure necessary to maintain full implementation of the standards in order to ensure long-term program sustainability.